Role of B2 in Brown Fat Transcription and Development

DESCRIPTION (provided by applicant): Obesity is a global health epidemic associated with several metabolic diseases, such as type 2 diabetes. While white adipose tissue (WAT) accumulates fat as energy storage that in excess results in obesity, brown adipose tissue (BAT) dissipates energy as heat via non-shivering thermogenesis. Recently, substantial functional BAT has been proven to be present even in adult humans-a finding which has generated considerable interest, since an increase in BAT activity may be protective against obesity. Inducing thermogenic genes such as uncoupling protein-1 (UCP1) and promoting BAT development could be therapeutic strategies for obesity. Thus, it is critical to elucidate the BAT transcriptional network. We have identified a novel zinc finger transcription factor, B2, which is preferentially expressed in BAT compared to WAT and other tissues and is induced drastically upon cold exposure. We found that B2 directly binds to and robustly activates the UCP1 promoter. The putative B2 binding element is found in the promoter regions of other BAT-enriched genes, and we detected binding and activation of PGC1α promoter by B2. B2 expression is increased during brown adipocyte differentiation. We found that constitutive expression of B2 enhances brown adipocyte differentiation, whereas shRNA knockdown inhibits differentiation. The B2 knockout mice that we have generated show drastically decreased BAT mass with abnormal brown adipocyte morphology and decreased expression of UCP1 and other BAT-enriched genes. The goal of this research is to understand how B2 activates UCP1 and other BAT genes and the role of B2 in the BAT development and function. Aim 1 is to examine the molecular mechanisms underlying B2 activation of UCP1 and other BAT-enriched genes and how B2 is induced upon cold exposure. Aim 2 is to investigate the role of B2 in brown adipocyte differentiation in vitro. Aim 3 is to employ gain- and loss-of function approaches in mice to examine the function of B2 in vivo. This research will contribute to the emerging field of BAT biology and may provide new targets for obesity therapeutics. PUBLIC HEALTH RELEVANCE: While white adipose tissue stores fat to increase adiposity, brown adipose tissue dissipates energy as heat for thermogenesis. This research is directed toward understanding the function of a brown adipocyte transcription factor that governs brown adipose tissue gene expression and development. Understanding the mechanism and signaling pathway for the action of this transcription factor will provide us novel targets to develop strategies to control obesity and associated diseases such as diabetes.

Public health relevance
While white adipose tissue stores fat to increase adiposity, brown adipose tissue dissipates energy as heat for thermogenesis. This research is directed toward understanding the function of a brown adipocyte transcription factor that governs brown adipose tissue gene expression and development. Understanding the mechanism and signaling pathway for the action of this transcription factor will provide us novel targets to develop strategies to control obesity and associated diseases such as diabetes.